Specialized Training in Anesthesiology Team Science

Abstract
The main goal of the Specialized Training in Anesthesiology Team Science (STAT) Program is to develop competent investigative anesthesiologists in broad areas of research including basic, clinical/translational, and outcomes research. This novel training plan allows for the creation of an interdisciplinary team of mentors to form innovative research projects using a collaborative team science approach. Our program structure ensures that each STAT trainee will have a unique individualized training plan that will assist them into entry-level, full-time, academic faculty positions in Anesthesiology. A mentorship team will be created for each STAT trainee which includes both extramurally-funded biomedical researchers and leaders with Anesthesiology to help guide their career development. A total of 32 participating faculty mentors representing 17 departments are categorized into the 3 main areas of research; basic science, clinical/translational, and outcomes. STAT trainees will be exposed to interdisciplinary research and undergo formalized training in grant/manuscript writing, biostatistics, rigor and responsibility in research, and cover ethical topics in research. The STAT track allows for a research-intensive experience during their clinical training which includes research elective time followed by 24 months of NIH-supported research following the completion of their residency. Our goal is to recruit, develop, and retain motivated individuals that will broaden the scope of research in Anesthesiology. The proposed training plan aims to continue the strong tradition of developing physician-scientists within the Department of Anesthesiology at MCW while branching out into various disciplines to perform cutting-edge research. Individuals who complete the STAT program will be well positioned to succeed in the academic environment, make impactful discoveries, and become future leaders in our field.

Public health relevance
Project Narrative The evolving needs of the specialty of Anesthesiology include: a strengthening of the scientific foundation to grow new fundamental insights and offer the highest quality of care to the expanding complex patient population requiring anesthesia perioperative care. The purpose of the STAT Training Program is to develop a subset of outstanding investigators trained to conduct precise and impactful research of relevance to anesthesiology and perioperative medicine.